Administrative Core

ABSTRACT The Administrative Core of the Boston Children’s Hospital/Harvard Medical School IDDRC enhances research and promotes the development of new therapies by supporting outstanding research focused on problems relevant to intellectual and developmental disabilities. The Core supports the financial and administrative management of core facilities, ensuring cost effectiveness and quality control, and fosters overall centeredness to enhance and encourage collaboration between IDDRC investigators. Importantly, the Administrative Core is charged with coordination of recruiting, training and supporting a diverse set of next generation of leaders in IDD research with particular emphasis on engaging under-represented minorities. By active engagement with other IDDRC cores and investigators throughout the national IDDRC network, the core services provided by our IDDRC promote collaboration outside the institution to speed the development of effective clinical interventions in intellectual and developmental disabilities. Through its specific aims, the Core (1) focuses the Center on problems of importance to IDD, (2) develops and maintains “state-of-the-art” Cores, (3) promotes a cohesive and interdisciplinary Center, (4) facilitates training the next generation of young investigators, (5) promotes collaboration of IDDRC investigators within the Center and throughout the IDDRC network, (6) optimizes Core utilization and efficiency, and (7) facilitates broad dissemination of IDD research to diverse audiences. The Administrative Core brings together the distinguished leadership for the IDDRC for scientific and programmatic planning and evaluation, including the Executive Committee, Internal Advisory Committee and Scientific Advisory Committee as well as engaging with families and Patient Advocacy Groups to ensure the Center’s research strategy aligns with the highest priority needs of the IDD community.